Desmoplakin Assembly and Function in Epidermis

By tethering the intermediate filament (IF) cytoskeleton to the plasma membrane, the desmosomal plaque
component desmoplakin (DP) strengthens adhesion mediated by the transmembrane desmosomal cadherins.
DP mutations result in potentially lethal disorders of the skin and heart. The loss of mechanical tissue integrity
caused by desmosome dysfunction is commonly thought to underlie disease pathogenesis. Duing this MERIT
award period, however, we showed that DP is not simply a physical connector. It is also a signaling scaffold that
tunes its own dynamic association with IF as well as the cortical actin cytoskeleton to modulate epithelial cell
mechanics. We identified previously unrecognized binding partners of an intrinsically disordered region (IDR) in
the DP C-terminus that makes the DP-IF complex tunable. How this DP scaffold changes as keratinocytes transit
from the basal proliferating layer to the superficial layers to meet the needs of the developing tissue is still poorly
understood. Our overarching hypothesis is that DP and associated plakophilins localize and integrate the
activities of signaling mediators and actomyosin modulators when and where they are needed for junction
assembly, adhesion strengthening, and epidermal morphogenesis. Here, we will use a combination of 2- and 3-
dimensional in vitro human models and DP-deficient human disease and animal models to: 1. Define the
mechanism of desmoplakin-intermediate filament complex formation and cooperation with desmosomal
cadherins to modulate adhesion and promote early epidermal morphogenesis. We hypothesize that DP
forms cytoplasmic precursors comprising plakophilins, actin regulators, RNAs, and RNA binding proteins
necessary for junction-associated actin polymerization, altered cell mechanics and cell fate. To test this, we will
define a) the machinery responsible for DP precursor formation, b) the role of the DP IDR as a stress sensor, c)
how DP cooperates with desmosomal cadherins to promote actin remodeling, and d) the role of DP in
stratification; 2. Determine the contribution of the desmoplakin-intermediate filament complex to late
epidermal morphogenesis and the tight junction barrier. We hypothesize that DP recruits Rho Guanine
nucleotide exchange factors (GEFs) and other maturation factors including phosphatases to locally activate
RhoA and strengthen DP-IF interactions, which in turn promotes high cortical tension and tight junction assembly
in superficial layers of the epidermis. To test this we will use genetically or pharmacologically targeted epidermal
cultures, mouse and human disease models of DP dysfunction to: a) evaluate Rho localization/activity, cell
mechanics and TJ structure/function in RhoGEF-deficient or DP mutant conditions with or without local
restoration of tension via optogenetic activation of RhoA, and b) evaluate the role of phosphatases (PP)1/2A and
associated DP post-translational modifications on cell mechanics and TJs. The proposed work will shed light on
how alterations in DP-IF protein networks tailor the cell cortex in each layer to support early and late events in
epidermal differentiation, and how interfering with this network contributes to cardiocutaneous disorders.

Public health relevance
Desmosomes are classically considered to provide mechanical support to the epidermis by connecting stress-resisting intermediate filaments to sites of cell-cell adhesion through the essential anchoring protein desmoplakin. But desmosomes are much more dynamic than this classic definition implies. Here we will determine what controls desmoplakin dynamics to create desmosomes with different properties during early and late stages of epidermal regeneration, and how interfering with these dynamics contributes to skin disease.